Sparking Advancements in Genomic Medicine

Project Summary
As part of the IGNITE II network, the Genetic testing to Understand Renal Disease Disparities in the U.S. (GUARDD-US)
clinical trial has been underway since July 2019. GUARDD-US is a prospective randomized pragmatic genotype-guided
clinical trial aimed at determining the effect of early vs. delayed knowledge of a positive APOL1 genotyping result on 3-
month systolic blood pressure (SBP). African Americans between 18 and 70 years of age with hypertension, with or without
chronic kidney disease (CKD) are recruited and randomized to immediate versus delayed return of APOL1 genetic testing.
In those who are APOL1 negative, a pilot study to test the impact of pharmacogenetic (PGx) testing on SBP is also
underway. The current administrative supplement request reflects a planned increase in enrollment for the GUARDD-US
trial. Because the observed prevalence the actionable APOL1 high-risk genotype is significantly lower than projected in the
initial sample size calculations (current 14.6% versus 17%), an increase in sample size from 5,435 to 6,600 is required to
ensure adequate power for analysis of the primary outcome. In addition, some sites have been unable to meet their
recruitment targets, and it is not anticipated that they will make up the shortfall expeditiously. The University of Florida
(UF) Clinical Group will support the GUARDD-US increased enrollment request by increasing its enrollment target by
40% (to 700 from 500 participants) and has agreed to add the University of Alabama at Birmingham as a member of its
Clinical Group to enroll an additional 300 research participants into the trial.

Public health relevance
Project Narrative People with African Ancestry have high rates of uncontrolled high blood pressure, chronic kidney disease and kidney failure, some with APOL1 positive genotype. We will test for APOL1 to see if early knowledge of high genetic risk improves blood pressure and we will contribute to the increased enrollment need of the GUARDD-US trial.